Clindamycin treatment for Bacterial Vaginosis: Identifying Subpopulations with EnhancedTherapeutic Outcomes

PROJECT SUMMARY/ABSTRACT
This proposal presents a five-year research career development program focused on the study of the
vaginal microbiome and its contributions to bacterial vaginosis (a highly recurrent and common gynecologic
condition), with the goal of expanding knowledge on mechanisms for treatment failure and better informing future
therapies. The candidate is currently an Assistant Professor of Gynecology and Obstetrics at Johns Hopkins
University School of Medicine. The outlined proposal builds on the candidate’s previous clinical experience in
recurrent vaginitis and integrates new domains of expertise in clinical investigation, the vaginal microbiome,
‘omics analysis, and bioinformatics. The proposed analyses and didactic work will position the candidate with a
unique set of cross disciplinary skills that will enable her to transition to independence as a physician scientist.
Bacterial vaginosis (BV), an alteration of the vaginal microbiome associated with vaginal discharge and
odor, affects one-third of reproductive age women. BV has been correlated with adverse outcomes including
preterm birth and increased risk of STI/HIV acquisition. It is unfortunately highly recurrent, with 25% of individuals
experiencing recurrence within 6 weeks of initial treatment and 60% within 1 year. Mechanisms for these poor
outcomes are not well understood, though recent data suggests that resistance to metronidazole (the most
commonly prescribed antibiotic for treatment) and Lactobacillus iners may play a role. The proposed research
aims to evaluate if these mechanisms are responsible for poor treatment outcomes and whether clindamycin,
the less commonly prescribed antibiotic for BV, may be more effective than metronidazole for certain individuals.
Clindamycin is hypothesized to be superior to metronidazole in those with metronidazole resistance, and for
those with Lactobacillus iners present prior to treatment, as it targets lactobacilli while metronidazole does not.
Theoretically, eliminating Lactobacillus iners, which is associated with frequent BV recurrences, may allow for a
more favorable Lactobacillus spp. to populate (L. crispatus, L. jensenii, L. gasseri: all associated with fewer BV
occurrences). The proposed aims will 1) determine the impact of clindamycin treatment on the vaginal
microbiota, focusing on Lactobacillus spp. post-treatment, 2) use metagenomics to identify markers of
metronidazole resistance and presence of L. iners pre- and immediately post- treatment, relating these factors
to clinical outcomes over 6 weeks, and 3) recruit a cohort of individuals with recurrent BV who are treated with
clindamycin, following closely with frequent vaginal sampling for 6 weeks post-treatment, characterizing
microbiome changes following treatment (specifically timing of Lactobacillus repopulation). The scientific
objective is to help inform future BV therapeutic approaches by identifying if clindamycin is a preferred treatment
either: 1) for a subset of individuals with BV (those with metronidazole resistance or L. iners present prior to
treatment) or 2) as pre-treatment prior to novel therapies such as live biotherapeutics (e.g., vaginal probiotics)
which aim to introduce favorable Lactobacillus spp. to the vaginal microbiome.

Public health relevance
Bacterial vaginosis (BV), an alteration of the vaginal microbiome, affects one-third of reproductive age women, is highly recurrent and is associated with adverse outcomes including preterm birth and increased risk of STIs/HIV. Mechanisms for frequent BV recurrence are not well understood, though recent evidence suggests Lactobacillus iners and antibiotic resistance to the most commonly prescribed antibiotic (metronidazole) may play a role. The proposed research will evaluate if these possible mechanisms are responsible for poor treatment outcomes as well as the impact of vaginal clindamycin (the less commonly prescribed antibiotic for BV) on the vaginal microbiota, as a first step to understanding whether clindamycin may be more effective for a subset of individuals, either as initial or pre-treatment prior to use of novel therapeutics.